Evaluation of antimicrobial prophylaxis to prevent syphilis in pregnancy in patients at risk in Rio de Janeiro, Brazil

PROJECT SUMMARY/ABSTRACT
There has been a dramatic resurgence in the number of congenital syphilis cases globally, including a very steep
rise in the number of cases in the U.S. In Brazil, congenital syphilis is an extremely serious health problem
despite numerous campaigns aimed at targeting eradication of syphilis during pregnancy. In the last 10 years,
the number of cases of syphilis in pregnancy in Rio de Janeiro has skyrocketed, with 1 to 2 of every 10 pregnant
patients who receive prenatal care in disenfranchised areas of the city testing positive for syphilis. This is 2 logs
higher than the already dramatic number of cases observed in the U.S. Rio de Janeiro currently has the highest
number of syphilis pregnancy cases in the country. Our group of researchers has a longstanding collaboration
in the field of infectious diseases, particularly vertical transmission of infections, which spans 3 decades, with
landmark clinical trials conducted such as NICHD HPTN 040 for prevention of intrapartum transmission of HIV.
The site in Brazil is a seasoned NICHD site with participation in many NIH-sponsored network studies since
1999, while the UCLA PI is a licensed physician in both the U.S. and Brazil, and a native of Rio de Janeiro. We
propose to conduct a randomized clinical trial for prevention of maternal syphilis during pregnancy, utilizing the
existing local health infrastructure and scientific methods developed in our prior studies, with the support of the
Brazilian Ministry of Health and local health departments which welcome this partnership given the urgent need
to address the ongoing syphilis crisis. The main goal of the proposed research is to prevent the development of
syphilis in pregnancy and congenital syphilis through enhanced serologic screening for syphilis during prenatal
care with point of care treponemal testing at 6, 7 and 8 months of pregnancy and monthly shots of benzathine
penicillin as syphilis prophylaxis to negative participants in the intervention arm as compared to standard of care
in pregnant patients randomized to the control arm (point of care testing three times during pregnancy). The
study will assess the number of patients screening positive for syphilis and the number of infants requiring
treatment for congenital syphilis in a study population comprised of 500 pregnant participants. Patients identified
with syphilis will be managed according to Brazilian standard of care guidelines which mirror CDC
recommendations. The study will assess tolerability, acceptability, and safety of benzathine penicillin while
evaluating maternal/ obstetrical and infant health parameters during pregnancy and at the time of birth. The data
rendered will be crucial for development of prevention efforts to curtail the syphilis epidemic.

Public health relevance
PROJECT NARRATIVE This proposal responds to the emergent need to address the global syphilis in pregnancy epidemic crisis that in Rio de Janeiro, affects 1 to 2 out of every 10 pregnant persons living in disenfranchised areas. Even though pregnant people are screened twice in prenatal care and once at the time of labor and delivery as per standard of care guidelines, incident syphilis cases during pregnancy continue to rise, fueling a parallel epidemic of congenital syphilis. Our research team, who has been collaborating for decades in the field of prevention of perinatal infections, proposes a randomized clinical trial of antimicrobial prophylaxis with monthly benzathine penicillin in the third trimester of pregnancy compared to standard of care among pregnant patients living in high prevalence areas for syphilis with data rendered being crucial for development of syphilis in pregnancy prevention programs.